Vet-LIRN Network Capacity-Building MiSeq i100 System for Testing Foodborne and Zoonotic Pathogens

Project Abstract
The University of Illinois (UI) Veterinary Diagnostic Laboratory (VDL) is a full service, AAVLD accredited, all
species, reference veterinary diagnostic laboratory. As a member laboratory of the FDA Vet-LIRN, UI VDL is
actively involved in several VET-LIRN activities including iSeq-sequencing Listeria project as a lead lab,
providing isolates for MiSeq WGS sequencing project as a source lab, participation on antimicrobial resistance
pilot project, and evaluation of automatic nucleic acid extraction methods as a lead lab. Old MiSeq System has
a longer turnaround time (19-56 hours) and complexed process for sequencing and equipment maintenance; by
contrast, the new MiSeq i100 System has much shorter turnaround time (4-15.5 hours), simple integrated fluidics
without additional equipment wash and library denaturation, and more versatile amplifications. Therefore, the
new MiSeq i100 System add more diagnostic values to clinical case investigation of foodborne pathogen related
outbreaks and other zoonotic diseases affecting both animals and humans. This funding support is crucial for
maintaining UI VDL capacity in molecular testing and critical response to animal food/drug emergency or disease
outbreak coordinated by FDA Vet-LIRN.

Public health relevance
Public Health Relevance Statement: Project Narrative The purpose of this proposal is to get support to purchase a new Illumina MiSeq i100 System to increase sample analyses for the FDA-Vet-LIRN in the event of an animal foodborne related illnesses. This will provide enhanced capacity in UI VDL for FDA Vet-LIRN surveillance assignments and routine case investigation of food-borne illness in animals.